Modeling and targeting intrinsic and extrinsic features of Myc-driven Osteosarcoma

Osteosarcoma (OS) is the most common bone tumor in pediatric patients. While defining genetic mutations are
rare for OS, somatic DNA copy number alterations (SCNA) are a hallmark of OS and are becoming a means
towards categorizing this complex, heterogeneous disease. One such SCNA is amplification of chromosome
8q24, which harbors the oncogene c-MYC, occurs in approximately 30% of OS patients. This molecular
subgroup of patients has a high-risk of relapse and overall poor prognosis when treated with the current standard
of care. However, targeting oncogenic transcription factors such as Myc through direct protein inhibition has
been a tremendous challenge, thus signifying the need to gain a comprehensive understanding of the complete
tumor biology in order to identify effective and actionable therapeutic regimens. Recent studies indicate that
oncogenes not only cause tumor-intrinsic molecular aberrations, but these intrinsic molecular defining traits can
cause extrinsic ramifications on the tumor microenvironment (TME), including regulating immune infiltrations.
The central hypothesis is that the Myc-amplified OS tumors confer unique intrinsic molecular signatures that
dictate extrinsic microenvironmental dynamics on OS cells. These unique molecular and cellular distinctions will
result in therapeutic vulnerabilities that can selectively inhibit Myc-amplified OS cells. Our proposal uses
complementary resources, including publically available databases and cross-species analysis of homologous
OS patient-derived xenografts (PDX) and genetically engineered mouse models (GEMM) we have garnered,
generated, and characterized towards dissecting and targeting the defining intrinsic and extrinsic Myc-amplified
molecular signatures. While the approaches are innovative, they are rational and achievable, with well-defined
OS resources, including immunocompetent models are readily available, thus demonstrating feasibility. AIM1:
Comprehensively characterize and genetically perturb cross-species molecular features of Myc-hyperactivated
human and murine OS tumors. We will define intrinsic and extrinsic single cell proteo-transcriptomic signatures
and cell-cell communications present in our murine and human primary and metastatic patient tumors. We will
also perform proof-of-concept genetic perturbation to disrupt candidate metastatic-associated cell-cell
communications. Subsequent bioinformatic analysis will provide additional candidate therapeutic avenues to be
streamlined into Aim3. AIM2: Determine the role of Myc in the reprogramming of immune suppressive TME in
OS. We will employ our dTAG-MYC to characterize Myc-dependent intrinsic and extrinsic effects on OS. We will
investigate the role of identified Myc-mediated immune modulators, specifically CCL9 (MIP-1ϒ) on T cell and
myeloid activity. AIM3: Novel combinatorial therapeutic approaches targeting Myc-hyperactivated tumors that
remodels the immune TME and consequently enhances targeted therapeutic efficacy. The long-term goal will
change the treatment paradigm by enabling early risk stratification, upfront targeted therapy, and enhanced
patient outcomes for this high-risk SCNA subgroup of OS patients.

Public health relevance
Somatic DNA copy number alterations (SCNA) of chromosome 8q24, which harbors the oncogene c-Myc, defines a subgroup of osteosarcoma patients with extremely poor outcomes regardless of the disease stage. Our lab has developed and characterized complementary models and resources, including cross-species analysis of murine transgenic, human patient samples models and resources and genomic datasets that harbor this amplification and mimic Myc hyperactivation, which have allowed us to begin dissecting the intrinsic and extrinsic cellular and molecular features and therapeutically investigate novel avenues for the treatment of this aggressive subgroup of OS tumors. Consequently, this project is particularly relevant to the NIH’s mission because it is uses highly innovative, translational studies towards the advancement of anti-cancer agents for the treatment of a highly aggressive pediatric cancer.